MYOFIBRILLAR DISRUPTION &MUSCLE PROTEIN SYNTHESIS FOLLOWING RESISTANCE EXERCISE

This study examined the relationship between myofibrillar disruption and muscle protein synthetic rate (MPS) following an isolated bout of concentric (Con) or eccentric (Ecc) resistance exercise in six strength-trained males. MPS was calculated from the enrichment of L-[1,2-13C2]leucine in biopsies using the primed, constant infusion technique with the midpoint of the assessment period being approximately 24 h post-exercise. We conclude that the Ecc phase of resistance exercise is most disruptive to skeletal muscle, that training attenuates this effect, and that exercise-induced fiber disruption is essentially repaired after 5 d of inactivity in trained subjects.